[RNW] - Gamete Interactions in Caenorhabditis elegans

RELEVANCE: Fertilization is a biological process with important medical, social
and economic implications. From extensive study, the events of fertilization are known in
some detail. However, the molecular underpinnings of these events generally remain
elusive. Most previous work on fertilization has relied on biochemical and immunological
approaches. Our work is groundbreaking in the application of classic gentic analysis to
this vital area of research.
RATIONALE: Many of the genetic and molecular tools developed for C. elegans
are not available or are very difficult to utilize in other organisms traditionally used for
studying fertilization. One of the most significant advantages of C. elegans is the ability
to isolate and maintain mutants that affect sperm or eggs and no other cells. Previously,
through the study of sterile mutants, we have identified some of the first molecules
required for productive gamete interactions in C. elegans. We propose to gain a better
understanding how the spe-13 and egg-7 genes function to ensure successful
fertilization. Mutations in both these genes lead to the production of morphologically
normal gametes that fail in fertilization. Futher, a full understanding of the molecular
mechanisms of fertilization is impossible without a more complete inventory of molecular
components. Therefore we aim to identify new fertilization molecules through genetic
and molecular analysis. Particular emphasis will be placed on the identification of genes
required in oocytes.
OBJECTIVES: The goal of this proposal is to further our understanding of
fertilization in C. elegans by conducting the following experimental aims: 1) Investigate
the function, interactions, and control of the cellular distribution of SPE-13. 2)
Investigate how EGG-7 impacts glycosylation and GPI-anchored protein pathways
required for fertilization. We will characterize human pathogenic variants for their effect
on C. elegans EGG-7 function. 3) Conduct a CRISPR/Cas9 engineered balancer-based
genetic screen for new fertilization mutants and determine the molecular nature of new
genes defined by a fertilization defective mutant phenotype. This work will complement
fertility studies in other organisms and provide molecular insights to the diversity of
reproductive strategies.

Public health relevance
Although the cellular events of fertilization are well described, the molecular underpinnings and genetic pathways that regulate the process are not well understood. We are identifying genes and molecular mechanisms of fertilization in the Caenorhabditis elegans model system. This work complements studies of fertilization in other species and could lead to a better understanding of the diversity of reproductive strategies in nature, causes of infertility, the design of new contraceptives, and a better understanding of human congenital disorders.